Task C08: Maintenance of Black Fly (Simulium Vittatum IS-7) Immature and Adult Stages

This contract provides for the development of new and refinement of existing animal replacement and non-traditional animal models and may include evaluation of candidate countermeasures.